Task B16: Model Development and Medical Countermeasures (MCMs) for BSL-4 Agents in NHPs

This contract provides for the development of new and refinement of non-human primate models of infectious diseases and may include evaluation of candidate countermeasures.